Mechanisms of Mammalian Genetic Hearing Loss

PROJECT SUMMARY
This work is designed to understand the mechanism of how the protein encoded by the human deafness gene,
TMPRSS3, leads to hair cell death and hearing loss. Hair cells are surrounded by apical tight junction protein
complexes, which form a barrier between the endolymph which covers the apical side of the hair cell and
perilymph, which covers the basolateral side of the hair cell. The endolymph contains a high potassium
concentration and high electrical charge, while the perilymph has low potassium concentration and low
electrical potential. Disruption of the apical tight junctions leads to permeability of endolymph K+ and death of
sensory hair cells. Variants in the multiple genes encoding tight junction proteins cause human deafness and
result in rapid hair cell degeneration during the rapid rise in endocochlear potential. This unique temporal
pattern of hair cell death mimics what is seen with variants in the gene encoding the serine protease,
TMPRSS3. Our preliminary data shows that loss of TMPRSS3 disrupts apical tight junction formation. We
hypothesize that TMPRSS3 functions to prevent hair cell degeneration by maintaining the tight junction barrier
between hair cells through proteolysis of tight junction related protein substrates. The goal of this application is
to define the biological mechanism of how loss of TMPRSS3 leads to disruption of tight junction function. In
Aim1, we will test if TMPRSS3-mediated hair cell death is dependent on the endocochlear potential in vivo and
we will determine if the location and/or proteolytic cleavage of tight junction proteins are altered in TMPRSS3-
deficient hair cells. Using immunohistochemical, biochemical and ultrastructure techniques, we will determine
how loss of TMPRSS3 physically alters tight junctions. Aim 2 we will use AAV-mediated gene delivery in vivo
to determine if TMPRSS3 function is protease dependent and if hearing loss variants TMPRSS3 are functional.
In Aim 3, we will use multiomic approaches in human stem cell-derived inner ear organoids to determine
transcriptomic and proteomic pathways regulated by TMPRSS3. By accomplishing these aims we will not only
advance our understanding of the molecular mechanism and protease substrates of TMPRSS3 in the inner
ear, but also gain insights into the dynamic regulation of tight junctions. This has the potential to impact
multiple forms for genetic deafness.

Public health relevance
PROJECT NARRATIVE Hearing loss affects more than 35 million adults and children in the United States and genetic variants play a major role in the survival of sensory cell within the inner ear. This project is directed at understanding how TMPRSS3, a protein that cuts other proteins, regulates the critical protein links around the sensory cells. The results may help us design strategies for treating inherited deafness.